Tumor-Associated Macrophages in Vasogenic Cerebral Edema in Brain Tumors

Project Summary:
Glioblastomas (GBM) are among the most lethal of all human cancers, with a median survival of around one
year. Vasogenic edema is a universal problem for GBM patients, and corticosteroids are commonly used
perioperatively to control cerebral edema and are frequently continued throughout subsequent treatment, notably
radiotherapy (RT), for the amelioration of side effects. Vasogenic edema is a significant cause of morbidity in
patients with both primary and metastatic brain tumors, both from the direct impact of edema and from indirect
effects related to the requirement for chronic corticosteroid use to manage it. In general, the mechanism of
edema formation is still unclear. We have shown that dexamethasone (DEX) administration significantly
compromises RT efficacy, together with emerging new therapies that augment the immune response to treat
brain tumors. Although we and others have identified antibodies and agents targeting vascular endothelial growth
factor (VEGF) at high anti-cancer doses that effectively reduce edema, their use is associated with increased
infiltration of tumor growth-promoting macrophages and development of resistance. Our preliminary and
published work identified the pro-inflammatory IL-1β from blood-born monocyte/monocyte-derived macrophages
(MDM) as a downstream target of DEX in exerting its anti-edema effect. We have shown that targeting IL-1β is
as sufficient as DEX in reducing edema but does not compromise RT efficacy. In contrast to anti-VEGFA antibody
treatment, targeting IL-1β does not induce increased infiltration of tumor-promoting TAMs; on the contrary, it
decreases the number of tumor-promoting TAMs and reduces the number of exhausted CD8+ T-cells. This
application thus aims to use three distinct genetically engineered mouse models of GBM that exhibit significant
differences in TAMs and anatomical structures of the brain-blood barrier (BBB), together with human primary
GBM patient-derived xenograft models, in combination with cell type specific IL-1β ablation strategies to
determine detailed mechanisms of IL-1β effects on vascular permeability and edema formation in GBM. The
proposed studies will provide new mechanistic insights into the fundamental cellular and molecular biology of IL-
1β in glioblastoma. The proposed studies test whether targeting IL-1β is a promising novel anti-edema therapy
for heterogeneous GBM with dual efficacy –against edema (in our renewal application) and neoplastic growth
that we demonstrated in our ongoing R01.

Public health relevance
Narrative (public health relevance statement): The grim prognosis and lack of therapeutic options for glioblastoma highlight the urgency of not only working towards developing novel treatment modalities but, in parallel, working on enhancing the efficacy of existing radiation and immunotherapy. By using a genetically engineered immunocompetent model of glioblastoma subtypes and primary human PDX models, this application aims to establish whether IL-1β serves as a compelling novel GBM anti-edema and anti-neoplastic therapy that is devoid of the severe side effects of DEX and anti-VEGFA; thus, it will have a significant impact on this disease.